Function of TCF-1 in antagonizing malignancy

The human immune system is naturally capable of killing cancer cells. But mutations and other
abnormalities handicap or neutralize it, making the immune system insufficient and ineffective.
Currently there is a lot of investment being made to study how to stimulate the immune system to
kill cancer cells. However, there is evidence that in certain circumstances boosting the immune
system actually encourages cancer cell growth. We’re trying to understand how this phenomenon
works. Particularly, under the circumstances when a TCF-1 gene mutation is involved — the
immune system, when stimulated, actually promotes the growth of lymphoma. We expect to learn
how TCF-1 gene regulates the immune responses to affect the lymphoma development.

Public health relevance
Project Narrative This project is to understand the function of TCF-1-regulated function in thymocytes and Th17 cells in the prevention of thymic lymphoma. This study will facilitate the development of effective treatments for lymphoma.